Cell-Mediated Targeted Redox Intervention for the Treatment and Prevention of Atherosclerosis

Abstract
I, Dr. Edward Bahnson, am a tenure-track assistant professor at the Department of Surgery at UNC. I have a
solid training in redox and vascular biology. I spent my post-doctoral training at the Vascular Surgery Divisions
at Northwestern University, where I gained further experience in translational research, and vascular biology.
Although I have a strong foundation, I require more training to ensure his development into a highly successful
independent researcher focusing on translational therapies for vascular disease. The overall goal of this
application is to provide me with precisely those skills through mentored and didactic training. Specifically, I will
focus on using nanotechnology and cell-mediated-based technologies to deliver redox-based therapeutics to
the diseased vasculature. This research area addresses key limitations in my previous experience. Particularly
the area of cell-mediated delivery and models of atherosclerosis. The training plan will allow mem to pursue
new highly novel translational research that is critical as I begin a new career as an Assistant Professor in the
Department of Surgery at UNC. To provide this training, I have has developed a comprehensive career
development and research plan. I will be mentored by Prof. Alexander Kabanov and co-mentored by Prof.
Nobuyo Maeda. As Director of the Center for Nanotechnology in Drug Delivery, Dr. Kabanov an expert in
nanoparticle design and characterization and the use of immune cells as delivery vehicles to sites of
inflammation. Dr. Nobuyo Maeda is the Robert H. Wagner Distinguished Professor of Pathology and
Laboratory Medicine. She is an expert in molecular genetics, and the creator of the apoE knockout mouse, the
first and most robust model of atherosclerosis. In addition to her technical expertise, Dr. Maeda has maintained
a vast interest in the training of young scientists. To facilitate his development further, I have established a
collaboration with Dr. Elena Batrakova, who has extensive experience in macrophage and macrophage derive
exosome-mediated drug delivery. The planned research will couple the power and innovation of nanoparticle
delivery of small molecule drugs, with cell-mediated specific targeting. Since I have demonstrated that redox
interventions are vasculoprotective in models of restenosis, I propose to use a redox approach as the
therapeutic agent in the treatment of atherosclerosis. Specifically, I propose to use the Nrf2 activators to affect
the redox status of atherosclerotic arteries locally early as soon as inflammation ensues. I have shown that
direct application of the Nrf2 activator Cinnamic Aldehyde, to the vascular wall activates Nrf2, reduces cell
proliferation and decreases oxidative stress. This suggests that targeted administration of Nrf 2 activators is
vasculoprotective and will decrease redox dysfunction in atherosclerosis. To deliver Nrf2 activators, I will
encapsulate the drugs in nanoparticles (NP). I hypothesize that macrophages will take up NP, localize to the
atherosclerotic plaque, and deliver redox-based therapeutic interventions.

Public health relevance
PROJECT NARRATIVE The overall goal of this proposal is to develop and evaluate a novel, delivery system to treat and prevent atherosclerosis. I plan to combine nanoscale carriers with cell-mediated delivery to target sites of vascular inflammation. The drug delivered will aim to re-establish redox homeostasis by activating the Nrf2 pathway.